Pyrimidine metabolism in the development of autoreactive B cells and SLE

PROJECT SUMMARY
Systemic lupus erythematosus (SLE) is a female-biased debilitating autoimmune disease that affects millions in
America and worldwide. Antibody-forming cells (AFCs) and germinal centers (GCs) promote the development of
autoreactive plasma cells (PCs) and the release of pathogenic autoantibodies (autoAbs) that are critical for the
initiation and progression of disease manifestations including lupus nephritis. Mechanisms that promote the
development of autoreactive B cells which drive SLE pathogenesis are incompletely understood. However, such
knowledge is instrumental for developing much needed therapeutics that are preferable to current SLE treatment
options that globally suppress the immune system and increase disease-associated morbidity and mortality.
Metabolic reprogramming has emerged as a critical mechanism that underpins SLE autoimmune responses and
disease progression. Various metabolic pathways are implicated in autoimmune responses in SLE. Although the
importance of nucleotide metabolism has been described in cancer and purines such as ATP are essential for
cellular metabolism, the role of pyrimidines in B cell metabolic reprogramming and responses in SLE is unknown.
Importantly, drugs targeting the pyrimidine pathway are FDA approved for the treatment of cancer and
rheumatoid arthritis. Drugs targeting the pyrimidine pathway is also considered for maintenance therapy for lupus
nephritis with no major toxicity. However, the role of pyrimidine metabolism in autoreactive B cell development
and pathogenic autoantibody (autoAb) production in AFC and GC pathways in SLE is not known. This grant will
focus on delineating the mechanisms by which pyrimidine synthesis promotes systemic autoimmunity. The
knowledge gained will be beneficial for dissecting mechanisms critical for B cell development and function and
may lead to novel therapies for SLE and other B cell-mediated diseases. Our preliminary data highlighted the
significance of de novo pyrimidine synthesis in autoreactive B cell responses in a SLE mouse model. Our data
also indicated an interplay of pyrimidine metabolism and B cell metabolic reprogramming in SLE-prone B cells.
Additional data pointed to a role for mTORc1, a master regulator of metabolism, in activating the pyrimidine
pathway in SLE-prone B cells. We hypothesize that B cell-intrinsic pyrimidine metabolism and an interplay of
de novo pyrimidine synthesis and metabolic networks promote autoreactive B cell development in AFC and GC
pathways, leading to autoAb production and SLE. This hypothesis will be tested by three specific aims. Aim-1
will, for the first time, identify the cell-intrinsic mechanisms of pyrimidine metabolism in autoreactive B cell
responses that promote the formation of autoAb-producing plasma cells and autoAbs in SLE. Aim-2 will
determine the interplay of pyrimidine synthesis and B cell metabolic networks that promote autoreactive B cell
development in SLE. Aim-3 will focus on the mechanism by which mTORc1 signaling drives the activation of de
novo pyrimidine synthesis pathway in SLE-prone B cells.

Public health relevance
Project Narrative Successful completion of proposed aims in the current R01 proposal will generate new knowledge and advance the field in our understanding of B cell-intrinsic mechanisms by which nucleotide metabolism in the pyrimidine pathway promotes autoreactive B cell development and autoantibody production in systemic lupus erythematosus (SLE). This proposal will help determine the interplay of pyrimidine synthesis and B cell metabolic networks that promote autoreactive B cell development and autoantibody production in SLE. Understanding mechanisms by which pyrimidine metabolism contributes to metabolic reprogramming and systemic autoimmunity may help develop targeted therapies for SLE.